Beckman Optima Multiwavelength Analytical Ultracentrifuge

Project Summary/Abstract
At the well-established X-ray crystallography facility at The Pennsylvania State University, we seek
funds for a Beckman Coulter multiwavelength Optima analytical ultracentrifuge (AUC) instrument equipped
with both UV-visible absorbance and Rayleigh interference optics. Partnered with the robust AUC
software, UltraScan and SedFIT, this will enable accurate size, shape, partial specific volume,
conformational change, molar mass, heterogeneity, binding thermodynamics and stoichiometry data on a
host of disease related biomolecules, bacterial, viral, motor, nucleosomal and intrinsically disordered
proteins, viral capsids, nucleic acids, liposomes and their complexes. No other functional AUC equipment
exists on any of our twenty-four Penn State campuses. A modern AUC capability, will enable us to cater
competently to the biophysical and structural characterization needs of our many exceptional NIH funded
faculty and support them in an integrated structural biology research. We have identified the Beckman AUC
Optima as the sole commercial product that meets our requirements, is state-of-the-art and cost-effective.
It features 0.001 cm radial resolution, scanning speeds up to 8 sec/channel in absorbance mode, and 5
sec/channel in interference mode. The high scan-speed, good resolution and superior sensitivity is
paramount for the success of the twenty-two cutting edge health care NIH projects and their applications
amenable to multiwavelength extinction detection including (a) protein complexes and oligomers in the
Dokholyan, Hancock, Weinert, Boehr, Cotruvo, Zhang and Nixon labs (b) protein nucleic acid complexes in
the Tan, Krasilnikov, Murakami, Grigoryev and Moustafa labs (c) liquid-liquid phase separated systems in
the Bevilacqua lab (d) intrinsically disordered proteins in the Showalter and Zhang labs (e) liposomes in the
Tian lab and (f) anaerobic metalloenzyme complexes in the Booker, Boal, Cotruvo and Weinert labs. The
ability to compliment the solution state AUC experiment with in-house multiangle light scattering, small angle
X-ray scattering and isothermal calorimetry prior to high resolution X-ray crystallography and cryoEM
studies would be a bonus. With this handshake, we are investing in true synergy where experimental results
from the AUC would guide the structural interpretation and binding thermodynamics. The equipment will be
used by eighteen structural biology faculty from two of our campuses, University Park and Hershey, and
three colleges, College of Medicine, Eberly College of Science, and the College of Engineering. With a
state-of-the-art multiwavelength Beckman Optima system, our goal is to ably resolve ultracentrifugation
data in the spectral and hydrodynamic domains in a wide size range of applications, for a large number of
users and enhance the capability at the Penn State X-ray crystallography core facility.

Public health relevance
Project Narrative We seek funds at the collaborative and productive X-ray crystallography core facility at The Pennsylvania State University, to equip with a Beckman Coulter multiwavelength Analytical Ultracentrifuge system for supporting the structural biology labs with the most accurate biophysical characterization of proteins, nucleic acids and their complexes. The eighteen faculty participating in the current proposal and the twenty-two outstanding healthcare NIH projects tackling a multitude of deadly diseases, such as cancer (Tan, Tian, Grigoryev, Hancock), cartilage hair hypoplasia (Krasilnikov), viral pathologies (Hafenstein, Bevilacqua, Boehr, Moustafa), diabetes (Showalter), protein misfolding disease (Cotruvo, Zhang), heart disease (Hancock), antibiotic resistance (Booker, Boal), amyotrophic lateral sclerosis (Dokholyan) and bacterial infections (Weinert, Murakami), would benefit immensely from this state-of-the-art enhancement.